LOW DOSE DEXAMETHASONE CHALLENGE--PERSONALITY DISORDER AND NORMAL CONTROLS

The purpose of this study is to further understand hypothalamic- pituitary-adrenal (HPA) axis functioning in subjects with borderline personality disorder (BPD).